FRET and Excitonic imaging of protein-protein interactions inside living cells

The objective of the Laboratory of Biophotonics and Quantum Biology is to develop new forms of microscopy and photometry to study protein-protein interactions under physiological conditions. Here we outline the current status of the three major projects in LBQB.

LBQB has three Specific Aims:

1) Utilize Binary-Forster Resonance Energy Transfer (FRET), our method for simultaneously monitoring two independent protein-protein interactions inside cells. We are using this approach to simultaneously monitor CaMKII activation and T-site ligand binding, to study CaMKII translocation into dendritic spines.

2) To investigate the mechanism of ultrafast energy transfer between fluorescent proteins and understanding the basis for coherent excitonic interactions between fluorescent proteins.

3) To develop a methodology for monitoring protein-protein interactions using deep-brain fiber photometry.

Specific Aim 1 This project is primarily under the direction of Dr. Nguyen and Dr. Puhl. Dr. Nguyen has demonstrated that homo-FRET and hetero-FRET can be measured simultaneously and that these measurements can follow independent changes in the proximity of homo-FRET and hetero-FRET pairs. Dr. Nguyen has demonstrated the utility of this approach by simultaneously monitoring the binding of a CaM-Kinase-II T-site ligand using hetero-FRET while simultaneously measuring a conformational change in the kinase holoenzyme structure associated with ligand binding using homo-FRET. In addition to generating constructs to support Dr. Nguyen's project, Dr. Puhl is also currently developing an in vivo assay in tissue culture cells based on bioluminescence for monitoring CaMKII – Calmodulin binding as well as CaMKII – NR2B binding in response to ATP triggered calcium influx. We are also collaborating with Dr.Khan (Lawrence Livermore Lab) to apply these approaches to CaMKII from primitive organisms to study the comparative evolution of CaMKII.

Specific Aim 2 Dr. Nguyen, in collaboration with Dr. Kim (University of Surrey) and Dr. Blank (NICHD) has been using time-resolved anisotropy, FCS, and antibunching to develop new analysis and instrumentation to investigate ultra-fast (faster than 140 ps) energy transfer between fluorescent proteins. We are also collaborating with Dr. Chen at UC Santa Cruz to use CD spectroscopy to detect coherent interactions between paired fluorescent proteins, and with Dr. Goodson (University of Michigan) to measure dephasing times and ultra-fast kinetics of fluorescent protein tandem dimers. Our results indicate that a coherent energy transfer mechanism is responsible for this unexpected high-speed energy transfer. We speculate that such a mechanism might have utility in developing quantum computers.

Specific Aim 3 In collaboration with Dr. Lovinger's laboratory (LIN) LBQB is developing photon-efficient fiber optic-based instrumentation to image FRET-based biosensors for cAMP and A-kinase activity in living mice based on monitoring changes in fluorescence lifetime.